Sensorimotor integration in the auditory dorsal stream

Project Summary/Abstract
Two cortical pathways originate from early core and belt areas of auditory cortex: a ventral pathway subserving
identification of sounds, and a dorsal pathway that was originally defined – similar to the visual system – as a
processing stream for space and motion. It has been proposed that the auditory dorsal pathway should be
reframed in a wider sense as a processing stream for sensorimotor integration and control (Rauschecker,
2011). This broader function explicitly includes spatial processing but also extends to the processing of
auditory-motor sequences, including spoken speech and musical melodies in humans. In this long-term
project, we will test the expanded model of the auditory dorsal stream by training rhesus monkeys to produce
sound sequences on a new behavioral apparatus (“monkey piano”) developed in our laboratory (Archakov et
al., 2020). By pressing a lever, the monkey produces a tone of a specific pitch; by pressing several levers in
succession, the monkey produces a melody. After an animal has learned to reliably play the same sequence,
auditory-responsive brain regions are identified through whole-brain functional magnetic resonance imaging
(fMRI) while the animal is alert and listens to the learned self-produced sequence. Control stimuli include
melodies the monkey has been passively exposed to, and novel melodies that the monkey has never heard
before. Results from the previous funding cycle show that listening to the self-produced melody activates not
only auditory areas but also motor regions of the brain, thus demonstrating the existence of internal models
linking perception and action. The locations of activated regions will now guide electrophysiological recording
with linear microelectrode arrays (LMAs). We will record neuronal responses in auditory and motor regions of
cortex to passive listening of the sound sequences and compare them to neuronal activity obtained when the
monkey actively produces the sequence with and without sound. Finally, we will add video of a monkey playing
the sound sequence on the monkey piano and study multisensory interactions along the dorsal stream using
fMRI and LMAs. In particular, responses in caudal auditory belt and parabelt will be compared with those in
premotor cortex and posterior parietal cortex in simultaneous recordings. Our studies, using alert monkeys
trained in a behavioral task, will contribute to the understanding of unified principles of perception and cognition
across sensory systems and their interactions with the motor system in the form of internal models.
Investigating the auditory dorsal stream in a nonhuman primate will provide essential information on the origin
of human communication, including speech and music. Our studies are relevant for higher–level processing
disorders of speech and its production, such as apraxia of speech, non-fluent aphasia, and specific language
disorders that involve inadequate coordination between sensory and motor systems. The results will also
improve our understanding of sensorimotor disorders, such as ataxia, which may be caused by stroke or
neurodegenerative disease, thus leading to better therapies and rehabilitation strategies.

Public health relevance
Project Narrative When we learn to sing or speak or play a musical instrument, our motor system has to produce the right sounds under auditory and visual guidance. To understand the neural mechanisms of this sensorimotor integration process, we will train rhesus monkeys in a novel behavioral task that allows them to produce sound sequences, and we will measure the monkey’s brain activity with functional MRI and MRI-guided electrode recordings. Our studies will elucidate the evolution of speech and music and will help to develop a better understanding of higher-level disorders of speech and language, including apraxia of speech and non-fluent aphasia.